Crosstalk of Immune Dysregulation and Impaired Wound Healing in inherited STAT4-mediated Autoinflammatory Disease

Abstract
Disabling pansclerotic morphea (DPM) is a severe, systemic disorder of childhood with debilitating skin, joint,
and mucosal symptoms, immune dysregulation and malignancy. DPM is known to be severely recalcitrant to
therapy, leading to death within 10 years of diagnosis. Our investigation of the specific contribution of STAT4 to
the immunodysregulatory phenotype seen in DPM patients revealed the following key observations: 1) The
STAT4 variant is a gain-of-function mutation that leads to impaired wound healing; 2) STAT4 variation leads to
an enhanced immunodysregulatory phenotype; 3) persistent phosphorylation of STAT4 results in IL-6
mediated autoinflammation; 4) JAK inhibition upstream can reduce IL-6 and improve wound healing in vitro
and in vivo. Based on our preliminary data we propose the CENTRAL HYPOTHESIS that gain-of-function
mutations in STAT4 lead to persistent JAK-STAT signaling due to steady STAT4 phosphorylation, erroneous
gene transcription, increased cytokine production, persistent systemic inflammation, and subsequently the
failure to regulate normal wound healing. To investigate our hypothesis, our proposal has the following
SPECIFIC AIMS. FIRST, we will determine the mechanism of STAT4 gain-of-function mediated immune
dysregulation in DPM. We will test the hypothesis that enhanced STAT4 activity leads to a failure of normal NK
and T cell development and cellular activation due to intrinsic defects in hematopoietic precursors leading to
altered differentiation and subsequent lymphocyte exhaustion from systemic inflammation using novel patient-
derived induced pluripotent stem cells (iPSCs) to examine development, transcriptomics, proteomics and
immune cell function. Human studies will be complemented by in vivo assays using knockin murine progenitor
cells, bone marrow cells, and peripheral cells at progressive stages of disease. SECOND, we will dissect the
role of enhanced STAT4 signaling in neovascularization and immune cell crosstalk. We will test the hypothesis
that gain-of-function mutations in STAT4 lead to upregulation of angiogenic factors that drive
neovascularization, life-threatening bleeds, and contribute to poor wound healing. We will characterize the role
of STAT4 signaling in endothelial cells and vessel formation by differentiation of patient-derived iPSCs to
endothelial cells. We will assess the competency of vessels in vitro, and the role of oxidative stress in
perpetuating poor wound healing. We will investigate translational mechanisms targeting JAK/STAT and
angiogenic pathways in DPM disease using transcriptomics of iPSC generated vessels. Finally, we will
investigate translational mechanisms targeting the JAK/STAT pathway in DPM.

Public health relevance
Project Narrative Impaired wound healing, vascular damage, and altered immunoregulation result in a devastating pediatric syndrome known as disabling pansclerotic morphea. We have uncovered a role for STAT4 as the genetic etiology underlying this autoinflammatory disease. The studies in this application will focus on targeting novel mechanisms of inflammation, angiogenesis, and immune-stromal crosstalk to understand the role of STAT4 in disease progression, in order to prevent morbidity and mortality associated with disabling pansclerotic morphea.